Cytoskeletal Regulation of Lung Endothelial Pathobiology in ARDS

ABSTRACT:
The critical role of lung endothelial cells (ECs) and the ARDS vascular endotype in ARDS pathobiology is
being dramatically highlighted in the current global COVID-19 pandemic. This highly translational PPG renewal
will address the contribution of unchecked EC permeability to the devastating multi-organ failure and mortality of
ARDS by providing a comprehensive understanding at the molecular and genomic level of vascular barrier reg-
ulation and repair. This renewal maintains its focus on the critical role of the EC cytoskeleton in the pathobiology
of ARDS and ventilator-induced lung injury (VILI) and seeks to directly address the unmet need for FDA-
approved ARDS pharmacotherapies that attenuate lung vascular permeability and inflammation. We propose
4 highly clinically-relevant, tightly-woven PPG Projects centered on specific lung EC target proteins/genes that
are involved in: i) the unchecked vascular permeability and injury in ARDS; ii) vascular responses to exces-
sive mechanical stress in VILI; iii) contributing to the genetic basis for ARDS health disparities in African
descent subjects; and, iv) providing novel ARDS therapeutic opportunities. Thematic integration across all
projects includes functional characterization of ARDS-associated SNPs and CpG sites in PPG target genes and
the role of ROS in transcriptional and biochemical regulation of peripheral cytoskeletal remodeling, formation of
cytoskeletal-driven lamellipodia and focal adhesion (FA) reorganization that promotes EC gap closure. Project
#1 will utilize system biology approaches to define novel cytoskeletal regulation of EC barrier responses by the
multi-functional non-muscle myosin light chain kinase isoform (nmMLCK) and its cytoskeletal-binding partner,
cortactin. Project #2 (a new PPG addition) extends our recent report that EC secretion of the damage-associated
molecular pattern (DAMP) protein, eNAMPT (nicotinamide phosphoribosyltransferase), is critical to ARDS in-
flammatory permeability and injury via eNAMPT ligation of the Toll-like receptor 4 (TLR4). Project #3 will inter-
rogate the novel regulation by integrin β4 (ITGB4) and kindlin2, of the bidirectional signaling between the cyto-
skeleton and focal adhesion (FA) dynamics which promotes lamellipodial-mediated closure of inflammation-in-
duced EC gaps. Project #4 (a new PPG Project) will elucidate interactions between key barrier-regulatory re-
ceptors: sphingosine-1-phosphate (S1P) receptor 1 (S1PR1), S1PR3, and P-selectin which regulate leukocyte
recruitment and lung vascular leak via ligation by P-selectin glycoprotein ligand 1 (PSGL1). Supported by four
highly interactive cores woven into each PPG Project (Administrative, Genome/Proteome, Preclinical Animal
Model, Biophysical Imaging), this PPG will continue to leverage the outstanding scientific environments at the
University of Arizona and University of Illinois, and the outstanding PPG translational team of interactive basic
and physician-scientist investigators. In addition to informing the genetic basis for ARDS health disparities, our
work directly addresses the urgent unmet needs for greater mechanistic understanding of lung EC barrier regu-
lation and novel therapeutics that restore the integrity of the injured lung circulation to reduce ARDS mortality.

Public health relevance
The global SARS-CoV-2/COVID-19 pandemic, with unprecedented mortality rates of COVID-induced ARDS, has dramatically highlighted the critical role of lung endothelial cell (EC) dysfunction and permeability, the lack of key insights into ARDS pathobiology, the lack of key insights into ARDS health disparities, and the absence of FDA-approved ARDS pharmacotherapies. This competitive PPG renewal application maintains its highly translational focus on a key ARDS target, the lung endothelial cell, and the essential role of the EC cytoskeleton in the pathobiology of ARDS with the vascular endothelium as a highly druggable target to attenuate lung vascular permeability and inflammation and ARDS mortality.